AFRICAN AMERICAN STUDY OF KIDNEY DISEASE AND HYPERTENSION (AASK)--FEASIBILITY

This NIDDK sponsored study is comparing the efficacy of different forms of antihypertensive drug therapy and different levels of blood pressure control in preventing progression of renal insufficiency in African-Americans with blood pressure related mild renal disease.